Center for Cellular Metabolism Research in Oklahoma

The goal of the parent COBRE award (P20GM139763) is to support research project leaders (RPL) to
scientific independence in area of cellular metabolism by creating and unifying resources under the COBRE-
supported Center of Cellular Metabolism Research in Oklahoma (CMRO). Dr. Chi Fung Lee has been
supported by the CMRO-COBRE as a RPL. The Lee lab has created a research program that investigates
how metabolism regulates heart disease progression. With the current COBRE support, the Lee lab is
examining mechanisms by which mitochondrial dysfunction and NAD+ redox imbalance promotes diabetic
cardiomyopathy. Patients with heart disease are associated with arrhythmias, which increase risks of patients
to heart failure, stroke and sudden death. In this supplement award, the Lee lab seeks support to continue a
collaboration with the Lam Lab at the University of Delaware on cardiac electrical/calcium signaling, and to
together examine the mechanistic roles of mitochondrial dysfunction and metabolism in arrhythmogenesis.
We aim to examine how mitochondrial metabolism regulates electrical/calcium signals to promote
arrhythmias, a hypothesis that has not been rigorously and directly tested. Dr. Chi Keung Lam was well-trained
in laboratories studying electrical/calcium signaling in mouse models and using induced pluripotent stem cell
platforms to identify mechanisms of arrhythmias. Our pilot data using cardiac-specific mitochondrial
dysfunction mice (Ndufs4-cKO) showed that mitochondrial dysfunction increases susceptibility of hearts to
arrhythmias and promotes sudden death. We found that calcium signaling is altered in cardiomyocytes isolated
from the arrhythmic Ndufs4-cKO hearts. In this supplement award, we plan to thoroughly characterize changes
in mitochondrial function and metabolism, and electrical/calcium signaling in these arrhythmias hearts.
To understand how mitochondrial dysfunction promotes atrial and ventricular arrhythmic events, we will
dissect spatial-specific changes (atrial and ventricular) using state-of-the-art electrical mapping (eMapping) of
the arrhythmic Ndufs4-cKO hearts available to the Lam lab. Spatial transcriptomic and metabolomic analyses
targeting cellular and mitochondrial metabolism will be used, available to the Lee lab. By coupling the expertise
of electrical/calcium signaling (Lam lab) and metabolism (Lee lab), this series of experiments will provide
important mechanistic targets to be further explored linking mitochondrial dysfunction to arrhythmias. Our
long-term goal is to apply for a multi-PIs R01 grant that dissects detailed molecular mechanisms how
mitochondrial metabolism regulates electrical/calcium signaling in arrhythmias. Our pilot data already support
one of the possible mechanisms in related to NAD+-dependent metabolic signaling altered by mitochondrial
dysfunction to deregulate calcium handling proteins (e.g. CaMKII acetylation). The complementary expertise
in the Lee and Lam labs will have synergistic effects in developing our young research programs and
understanding novel mechanisms of arrhythmias.

Public health relevance
PROJECT NARRATIVE Arrhythmias increase risk of patients to heart failure, stroke and sudden death; therefore, new therapeutic targets for this unmet medical need are urgently needed. We hypothesize that mitochondrial dysfunction alters metabolism and electrical signaling of the hearts as mechanisms to increase susceptibility of hearts to arrhythmias. In this supplement award, we couple resources and expertise in cardiac metabolism (Lee lab, OMRF) with calcium/electrical signaling (Lam lab, University of Delaware) to test this hypothesis and identify novel mechanistic targets.